Health and Discharge Outcomes among Younger and Older Nursing Home Residents

We have completed all the analyses using the NNHS data and updated literature as we are preparing the manuscript for publication. We have identified specific data of interest and have recently gathered information (e.g., documentation of CMS data files, application forms) to prepare a data request to the Research Data Assistance Center (ResDAC)-CMS. This project will be conducted under an inter-agency agreement between the NIH Clinical Center and the CMS. Publications generated by this year's research: No publications are associated with this Annual Report